Treatment Utilization During Community Reentry of Opioid Use Disorder Inpatients

Project Summary/Abstract
Nearly 400,000 people with an opioid use disorder (OUD) receive OUD treatment each year (19.7% of all
people with an OUD). Community re-entry following residential OUD treatment is a critically vulnerable time, as
risk of return to use, overdose, and death are increased in the 30 days following discharge.
Continuity of care
during re-entry is vital in supporting recovery outcomes, but little is known about treatment utilization during this
high-risk period. Individual and socio-structural factors can influence treatment utilization; however, there is a
dearth of information regarding the factors that predict treatment utilization during re-entry. Characterizing
treatment utilization and identifying predictors of treatment engagement is necessary to detect those who are
at risk for not engaging with treatment during community re-entry and thus address critical gaps in the OUD
treatment pipeline. By defining treatment broadly, inclusive of harm reduction strategies, and combining
intensive longitudinal methods (ecological momentary assessment [EMA]) with innovative machine learning
analyses, this study will both characterize treatment utilization with greater precision and improve prediction of
treatment engagement during community re-entry. Our findings aim to identify (in residential OUD treatment)
those at risk for not engaging with treatment during community re-entry (to inform preventative interventions)
as well as to pinpoint proximal facilitators and barriers to treatment utilization during community re-entry.
The proposed secondary data analysis aims to characterize treatment utilization and identify individual and
structural facilitators and barriers to, and predictors of, OUD treatment during community re-entry. The target
population is adults with OUD who discharged from residential OUD treatment (N=150). This study uses
innovative methods and cutting-edge data analyses to maximize existing data from the Sponsor’s NIH-funded
study (P20GM125507). Aim 1 uses EMA to accurately and reliably describe experiences with treatment
utilization during community re-entry. Aim 2 applies innovative machine learning modeling approaches to 1)
socio-structural and clinical data gathered during residential treatment to identify those at risk for not engaging
with treatment during community re-entry, and 2) symptoms and behaviors gathered during community re-entry
with EMA to identify facilitators and barriers to treatment utilization the re-entry period. Findings will inform
continuity of care, evidence-based tools to prevent and/or delay return to opioid use, and reduce harms
associated with community re-entry. This proposal addresses critical gaps in my training and knowledge
and will be necessary to develop an independent, NIH-funded research program focused on opioid use
and OUD treatment utilization during high-risk transitional periods, such as community re-entry.

Public health relevance
Project Narrative Community re-entry following residential opioid use disorder (OUD) treatment is a characterized by high rates of return to use, overdose, and death, yet little is known about treatment utilization during this extremely high- risk transitional period. Characterizing treatment utilization during this vulnerable, time-sensitive window is an important next step in research. By describing treatment utilization (i.e., type, timing, and frequency), and identifying facilitators, barriers, and predictors to treatment utilization, this project will inform best practices for continuity of care and development of evidence-based tools that may delay and/or prevent return to opioid use.